Optimizing the use of noninvasive respiratory support in the Emergency Department

PROJECT SUMMARY
The goal of Dr. Neha Goel’s K23 project is to enable her to become an independent physician-investigator who
conducts research on the implementation of evidence-based care for patients with acute respiratory failure.
Building upon her strengths as a pulmonary-critical care physician and her prior training in clinical emergency
care research, Dr. Goel will transition into the next phase of her career through a well-defined training plan. The
training plan is meticulously designed to enable her to acquire requisite skills in guideline development,
implementation science methodology, and advanced statistical analyses. Her career development plan contains
focused training through conduct of a mentored research study, relevant didactic coursework, and close
mentorship from leaders in the fields of emergency and critical care medicine, and implementation science.
Dr. Goel’s ultimate research objective is to improve clinical outcomes for patients with acute respiratory failure
through the implementation of a systematically developed, evidence-based, high flow nasal oxygen (HFNO)
monitoring protocol for the emergency department (ED). In keeping with this objective, her K23 mentored
research project will focus on investigating the implementation of evidence-based protocol on HFNO use and
management for The Mount Sinai Hospital ED. HFNO use and management is a timely and important research
topic. Since the COVID-19 pandemic began, there has been a rapid increase in HFNO usage. However,
guidance on HFNO use and monitoring in the ED setting is lacking, and adverse clinical outcomes occur in the
absence of guidance. Dr. Goel’s K23 research project specific aims are to: (Aim 1) develop a pragmatic protocol
for HFNO use and management in ED setting for hypoxemic acute respiratory failure using feedback from a
national panel of multi-disciplinary experts and current evidence; (Aim 2) select implementation strategies that
address the determinants of protocol-concordant HFNO use and management, commensurate with the ED’s
capabilities, resources, and needs of its patients; and (Aim 3) examine both the implementation process for the
HFNO protocol and the applicable clinical outcomes in a pilot hybrid effectiveness-implementation study. The
completed project will include an implementation plan for HFNO management in the ED setting, and will provide
estimates of effect and sample sizes for a future R01 implementing and testing the impact of HFNO monitoring
protocols across health systems. Using the skills and preliminary data gained throughout this K23 mentored
career development project, Dr. Goel will be well positioned to become an independent physician-scientist with
R01 funding to implement and test the effectiveness of respiratory care protocols for improving patient and
process outcomes across health systems. Larger scale implementation of such interventions can help
standardized care delivery, with the ultimate goal of improving patient outcomes for more than a million acutely
ill patients presenting to EDs annually in the United States with respiratory complaints.

Public health relevance
PROJECT NARRATIVE There is substantial variability in adherence to evidence-based clinical management leading to inconsistent quality of care for acute respiratory failure. Using implementation science methodology, Dr. Goel’s K23 research aims to enhance adherence to evidence-based guidelines and improve care and clinical outcomes for patients presenting to the emergency departments with acute respiratory failure.